Project 4: Clinical Development of Therapeutic Strategies Targeting DNA Damage Repair

PROJECT SUMMARY/NARRATIVE
Metastatic prostate cancer (mPC) is a lethal disease with essentially no curative therapy. However, in unselected
patients, widely divergent responses to conventional and experimental therapeutics are routinely observed, with
occasional ‘outlier’ or ‘exceptional’ responders exhibiting durable complete responses and others exhibiting
immediate disease progression. This diversity suggests that underlying biological mechanisms accounting for
treatment responses can be identified and exploited to prioritize specific therapeutics predicted to have benefit
and avoid treatments predicted to lack activity.
The genomic landscapes of mPC demonstrate that a substantial fraction of mPC tumors harbor somatic defects
in DNA repair genes (DRGs) including BRCA1, BRCA2, ATM, MSH2/6 and others. This finding has important
treatment ramifications as a substantial body of preclinical and clinical work indicates that particular types of
DNA repair deficiency, particularly Homology Directed Repair (HDR) Deficiency (HDR-D) result in heightened
vulnerabilities to at least two drug classes: platinum (PLAT) chemotherapy and PARP inhibitors (PARPi). Also
of importance, tumors without a HDR-D genotype/phenotype are less responsive to these drugs.
In this proposal we will test the hypothesis that specific aberrations (germ-line or somatic) in genes involved in
repairing DNA strand breaks by HDR are predictive of meaningful clinical responses to FDA-approved genotoxic
therapeutics and drugs that impair mechanisms of repairing DNA. We will also determine if rational combinations
of novel therapeutics targeting DNA repair processes or inducing DNA damage in cancers with HRD will bypass
or overwhelm resistance pathways. We have 3 aims:
Specific Aim 1: Conduct Phase 2 clinical trials of genotoxic therapeutics in patients with mCRPC to determine
response rates, identify resistance mechanisms, and establish associations between specific HDR genomic
defects and the depth and duration of clinical responses.
Specific Aim 2: Evaluate rational combinations of pharmacological agents targeting DNA repair pathways using
Patient Derived Xenograft (PDX) models of mCRPC with inherent or engineered HDR aberrations.
Specific Aim 3: Develop minimally-invasive biomarkers involving the capture and analysis of circulating tumor
DNA capable of distinguishing patients for therapeutics targeting DNA repair pathways.

Public health relevance
PROJECT NARRATIVE The importance and relevance of this project centers on developing a new standard of care involving a targeted therapy for DNA repair deficient prostate cancer, to reduce the morbidity and mortality attributable to advanced prostate cancer and motivate studies designed to use individualized approaches to prioritize therapeutics likely to have substantial benefit in specific patient populations.